Evaluation of Antibody Responses Elicited by Zika Vaccination in Flavivirus-naïve and -experienced Individuals

Project Title: Evaluation of Antibody Responses Elicited by Zika Vaccination in Flavivirus-naïve and -
experienced Individuals
Project Summary
Zika virus (ZIKV) is a member of the flavivirus genus that recently precipitated widespread cases of neurological
pathology and congenital neurologic defects. In response, a multilateral coalition of investigators designed and
developed multiple vaccine candidates that elicited potent ZIKV-neutralizing antibodies, which were shown to
correlate with disease protection in animal models. Despite these advances, it remains unclear how the ZIKV
immunization antibody response is shaped in humans with and without prior exposure to other flaviviruses, such
as dengue virus (DENV), Japanese encephalitis (JEV) or yellow fever virus (YFV); particularly as these viruses
all have significant epidemiologic overlap with ZIKV. Our long-term goal is to understand the underlying humoral
mechanisms generated by flavivirus vaccination, which can provide long-term protection in flavivirus-naïve
and/or -experienced populations. Such information would guide vaccination strategies in flavivirus-endemic
areas or among flavivirus-naïve individuals traveling to endemic areas. The overall objective of this proposed
research is to evaluate the specificity and function of the B cell repertoire elicited by ZIKV vaccination in flavivirus-
naïve and -experienced individuals. To achieve these goals, this research will utilize leading-edge technologies
to sequence B cell receptors (BCRs) from flavivirus-specific, single B cells using RNAseq and Next Generation
Sequencing (NGS). BCRs will be compared between Zika vaccinated individuals, and to previously published
monoclonal antibodies, to determine the prevalence of B cell lineages, gene assignment, degree of somatic
hypermutation (SHM), and lengths of heavy chain complementary-determining region 3 (HCDR3). Common B
cell lineages will be expressed as monoclonal antibodies and evaluated for their specificity, function, structural,
and ability to protect against flavivirus challenges in mouse models. A total of 40 samples will be evaluated from
individuals representing 5 groups in 3 different Phase I Zika vaccine clinical trials: a) Flavivirus-naïve individuals
who were vaccinated using a Zika purified inactivated whole virus vaccine (ZPIV) b) Flavivirus-naïve individuals
who were vaccinated with an adeno-vectored Zika M-E (Ad26.ZIKV.M-Env) c) Individuals living in Puerto Rico
with prior dengue infection who were ZPIV vaccinated d) JEV (IXIARO®) vaccinated individuals who were ZPIV
vaccinated and e) YFV (YV-VAX®) vaccinated individuals who were ZPIV vaccinated. Flavivirus-naïve, Zika
vaccinated individuals (Groups a-b) will be explored in Aim 1 and Flavivirus-experienced individuals, either by
prior infection (Group c) or by prior vaccination (Groups d-e), will be explored in Aim 2. Aim 3 will examine a late
timepoint (6 months) following the last ZPIV vaccination to determine the longevity of the circulating B cell
lineages characterized in Aims 1 and 2. Evaluating prevalent B cell lineages responding to Zika vaccination will
reveal the specificity, function and durability of the humoral response among individuals living in different regions.
These studies will provide insights into the potency and durability of ZIKV vaccine responses in both flavivirus-
naïve and -experienced individuals and may translate into vaccine strategies that yield long-lived protection.

Public health relevance
Project Title: Evaluation of Antibody Responses Elicited by Zika Vaccination in Flavivirus-naïve and - experienced Individuals PROJECT NARRATIVE: Vaccination is a fundamental tool used to protect individuals from infectious diseases. This research will provide a thorough understanding of antibody responses to Zika vaccination in individuals who live in flavivirus- endemic and non-endemic regions, and translate into viable vaccine strategies to protect individuals living in or traveling to endemic areas where Zika virus and potentially other flavivirus infections, such as dengue, co- circulate.